Neural Network Models Constrained by Multiscale Data to Infer Minimal Functional Motifs in the Brain

Abstract
State-of-the-art computational approaches offer powerful tools to model the biological brain, but the models are
typically ‘single-scale’, or built to match a fixed level of abstraction. Such single-scale models have limited
ability to generalize to other levels or scales, preventing the inference of mechanisms that align with real
biology. There is a critical need for models that bridge data across spatiotemporal scales and levels of
description to enable mechanistic understandings of brain function in health and disease, but producing such
models requires innovative technical and conceptual developments to incorporate multiple scales or levels.
Recurrent neural network (RNN) modeling offers a powerful approach to overcome past technical limitations to
fill this need. In prior work, we developed data-constrained RNNs built on neural dynamics data from multiple
brain regions to successfully predict behaviors. Now, preliminary findings suggest that we can further adapt
and build on these models to achieve models capable of incorporating data at multiple levels or scales. Indeed,
our preliminary work indicates that RNN models with multiple constraints yield more consistent mechanistic
inferences across individuals and datasets, are more robust to noise, and a smaller solution space relative to
single-level models. These advantages suggest that we can significantly advance our RNNs by simultaneously
constraining them by data across multiple scales to develop multiscale RNN models. In response to
RFA-EB-20-002, we will apply these new models to decision-making as a use case, and we expect this work to
generate a new integrative theory to infer mechanisms across scales and study their collective contributions to
adaptive and maladaptive behaviors. Further, we propose that adding multiple biological constraints could
enable models to capture structures that are conserved across individuals and species during the same
behavior. With this new conceptual framework, we will test whether multiscale RNN models can uncover
functional motifs: ensembles of active neurons, independent of brain areas, that mediate key behaviors.
Leveraging existing datasets including connectomics/inter-area circuitry, neural dynamics, and behavioral data
across species with small, densely sampled nervous systems and those with large, sparsely sampled nervous
systems, our aims are to: 1) Build multiscale RNN models with biologically realistic priors based on
connectivity, neural dynamics, and behavior; 2) Deploy unsupervised methods to extract functional motifs from
data-constrained RNNs; and 3) Disseminate our models and methods. Scientific results from the proposed
aims will position multiscale RNNs as a novel and innovative class of models for mechanism discovery in
neuroscience and functional motifs as a fundamental mechanistic principle linking brain structure and
function. We will work closely with our growing network of collaborative end-users to deploy and test our
pipeline to facilitate wide adoption of the resultant tools, methods, and frameworks for further discovery.

Public health relevance
Narrative Computational models offer crucial tools to the neuroscience community to advance discovery of how the brain functions, but most models cannot simultaneously incorporate different types of data generated by neuroscience experiments. This project will develop new ‘multiscale’ models that enable researchers to identify mechanisms of brain function by simultaneously integrating multiple types of data from diverse animal species. The tools, models, and methods will be available through open-source platforms to promote wide adoption throughout the community.